Research grants administration capacity strengthening in South America

PROJECT SUMMARY/ABSTRACT
The main objective of this proposal is to improve administrative and financial oversight of NIAID grants and to
enhance compliance with regulations that govern awards from NIH and other Federal sponsors at the Instituto
de Efectividad Clínica y Sanitaria (IECS), and other research institutions in South America. This will strengthen
IECS grant management capacity and provide a supportive environment for investigators by relieving them of
administrative burdens and giving them the freedom to increase productivity in their research endeavors.
Aim 1: to strengthen IECS capacity to manage NIAID/NIH grants in accordance with their high standards and
regulations: new or revised grants management processes will be generated resulting from the best practices
learned by two IECS senior grants administrators who will attend two training sessions at the US host
institution -Tulane University of Louisiana-, a NIH regional workshop on program funding and grants
administration, or a NIAID post-award grants policy and management training event, and five days of in-house
training with the Grants Management Program (GMP) at NIAID. IECS grant administrators trained under this
award will increase their own capacity for administrative and financial oversight of NIH grants, they will train
other IECS support personnel, and they will implement changes or improvements to grants management
activities at IECS.
Aim 2: to share knowledge on NIAID/NIH grant management at the institutional, national, and regional levels:
IECS will create a repository of grant management tools that can be easily accessed by investigators and
support personnel. To make these tools available to a larger community of colleagues, we will also lay the
groundwork for building a Grant Administrators Community of Practice (GACoP) in South America.

Public health relevance
PROJECT NARRATIVE LMICs’ research institutions are limited in institutional competitiveness and productivity due to scarcity of resources to set well-functioning research administration operations. Strengthening administrative infrastructure to support grant application preparation, submission, and management in the South American region is a challenge to equitable research that needs to be addressed. Good research management provides assistance to researchers in finding funding, guides them through the complexity of funders requirements and procedures, generates tools, and ensures compliance with research good practices. The introduction of good business practices for managing awards; and assisting the administrative staff in developing and implementing standard operating procedures, will result in more efficient and transparent funded-projects management, as well as increased compliance with NIH grant policies.